Capturing the Dynamics of Homelessness through Ethnography and Mobile Technology

Background: On a given night around 40,000 Veterans are homeless and another 300,000 are at risk. Many
of these Veterans have complex health and social needs, and they experience frequent residential transitions
which can disrupt access to healthcare and treatment adherence. Many persons who are housing unstable
experience frequent residential transitions, such as from transitional housing to shelter, or from doubled up with
family/friend to living out of a car. Disruptions caused by such transitions likely contribute to this population's
poor health by interfering with access to care and treatment adherence. Despite the potential harm, there is a
major gap in detailed, contextual knowledge of these transitions, especially from the perspective of the
individuals experiencing them – such as their in-the-moment emotions, behaviors, geographic movements, and
social support. Filling this gap would improve knowledge of Veterans' trajectories into and out of
homelessness and their day-to-day barriers to health care and other services. New approaches are needed.
Research has shown that most persons experiencing homelessness have mobile phones, and increasingly
they are smartphones. This provides an opportunity to gather near real-time information, at relatively low cost,
that would help improve understanding of Veterans' changes in housing, health, mood, and use of services.
Significance/Impact: Homelessness among Veterans represents one of the worst failures of our national and
VA health care and social service systems. Health is poor, and life expectancy for homeless persons is 10 to
20 years shorter than for housed populations. The work proposed here will contribute to VA priorities of
improving access to care, increasing virtual care/telehealth, and improving the health of homeless Veterans.
Innovation: We propose the first significant test of passive and active mobile phone data collection among
homeless Veterans, including the use of global positioning system (GPS) location and ecological momentary
assessment (EMA) to improve understanding of context, mobility, and distance to services. These methods
can change how health services researchers think about collecting data from marginalized and hidden
populations. These techniques can identify sequences of micro-temporal events, for example teasing apart the
events and experiences that immediately precede (and follow) the transition from one housing type to the next,
or the events that led to a missed healthcare opportunity (e.g. a missed appointment).
Specific Aims: This study assesses the feasibility of smartphone data collection from homeless Veterans.
Aim 1: Characterize the real-time lived experience of homeless Veterans, including day-to-day activities,
interactions with services, and residential transitions using a formative ethnographic approach;
Aim 2: Refine and tailor smartphone data collection methods;
Aim 3: Conduct a 4-week demonstration of smartphone data collection to evaluate its acceptability and
feasibility with Veterans experiencing homelessness. Integrate quantitative (GPS, EMA, mobile survey,
medical records) and qualitative data; identify distinct patterns (or typologies) of residential transitions; and,
assess associations among residential transitions, mobility, mood, health services, and adherence.
Methodology: Ethnographic interview methods are used in Aim 1; focus groups and usability assessments in
Aim 2; and smartphone data collection in Aim 3.
Next Steps/Implementation: Using the methods and findings from this study, next steps will be to develop
interventions to identify and intervene at timepoints when there is rapid deterioration in Veterans' housing
stability or health to prevent major housing disruptions and health crises. Interventions will also contribute to
enhancing access to care and adherence to treatments.

Public health relevance
There are about 40,000 Veterans experiencing homelessness, and another 300,000 at risk. Their health is generally poor, and their lives are shortened by 10 to 20 years. This project seeks to improve homeless Veterans' access to healthcare services and treatments. To do this, it is important to better understand Veterans' transitions into homelessness, or from one unstable situation to the next, such as from cohabiting with family or a friend to living in a homeless shelter. The knowledge of these transitions, especially from the perspective of the individuals experiencing them – such as their in-the-moment emotions, behaviors, and geographic movements, could inform interventions that prevent Veterans' rapid deterioration in housing or in health. This study examines the usefulness of smartphones to collect information from Veterans in near real- time as the transitions are occurring. It will lead to new programs for Veterans at risk of or experiencing homelessness to assist them before housing instability worsens, and before health crises occur.